Integrating Genomics and Metabolomics to Develop Predictive Models of Prostate Cancer in Multiethnic Men

PROJECT SUMMARY/ABSTRACT
Prostate cancer (PCa) is the second leading cause of cancer death among American men, with men of African
ancestry have the highest PCa incidence and mortality rates. While the causes of this notable health disparity
are unknown, there is evidence of genetic contributions and it is likely that environmental factors contribute as
well. However, most PCa research has focused on men of European descent, particularly genome-wide
association studies (GWAS), which has resulted in polygenic models having poorer predictive value in non-
Europeans. The overarching goal of this research is to identify genomic and metabolomic factors that contribute
to PCa risk in multiethnic men. To facilitate the construction of a genome-wide multiethnic polygenic risk score
(PRS), in the K99 phase of this research, Dr. Darst will develop a novel variant selection algorithm to identify
informative variants among genome-wide data (Aim 1). She will then construct a multiethnic genome-wide PRS
using a large multiethnic PCa sample (PRACTICAL, N=237,380) (Aim 2). This PRS will be developed on overall
PCa (Aim 1A), aggressive PCa (Aim 2B), and age of PCa onset (Aim 2C) and is expected to lead to improved
predictive value compared to a PRS of ~150 known variants and to a PRS developed using Europeans only. Dr.
Darst's expertise in genetic epidemiology will be complemented with additional training in cancer epidemiology,
advanced statistical genomics, and cancer health disparities received through coursework, seminars,
conferences, and guidance provided by her expert mentoring team. In the R00 phase, Dr. Darst will initiate a
new line of research the applies integrative techniques to investigate combined genomic and metabolomic
factors influencing PCa risk. This will build directly upon the research and training received in the K99 period.
She will identify genetically-regulated metabolites that could be causally associated with PCa in multiethnic
populations (Aim 3). This will require developing a large multiethnic metabolomics imputation panel and using
subsequent meta-analysis summary statistics to develop genome-wide multiethnic PRS for each investigated
metabolite. These PRS will be used to impute metabolomics into the PRACTICAL consortium. A metabolome-
wide association study will then be performed to identify imputed, or genetically-regulated, metabolite levels that
are predictive of overall PCa or aggressive PCa. Using a subset of 1,186 African American men from the
Multiethnic Cohort (MEC) and the Prostate, Lung, Colorectal, and Ovarian (PLCO) Cancer Screening Trial, Dr.
Darst will investigate metabolites that could mediate the effects of genetic factors, including the PRS from Aim
2, on overall and aggressive PCa (Aim 4a). She will also use integrative techniques to identify genomic and
metabolomic factors that distinguish subgroups of individuals with high PCa risk (Aim 4b). Results are expected
to substantially improve our ability to detect high risk individuals who would benefit from earlier or more intensive
PCa screening across multiethnic populations and provide novel biological mechanisms to target for preventative
measures, likely reducing PCa mortality and the number of indolent PCa cases treated unnecessarily.

Public health relevance
PROJECT NARRATIVE This investigation is focused on identifying polygenic and metabolomic factors that contribute to prostate cancer risk in multiethnic men. Results from this research are expected to substantially contribute to our knowledge of the underlying mechanisms that contribute to prostate cancer risk and health disparities and improve predictive models of prostate cancer across ethnic and racial populations. This would improve our ability to detect high risk individuals who would benefit from earlier or more intensive screening and provide novel biological mechanisms to target for preventative measures, likely reducing prostate cancer mortality and the number of indolent cases treated unnecessarily.